Memory CD4 T cell driven antibody responses to renal allografts

Despite improved immunosuppression and roufine PRA screening, alloreacfive anfibodies (alloAb) mediate a significant proportion of acute allograft rejection episodes and contribute to the development of chronic rejection. Production of pathogenic alloAb isotypes requires interactions between B cells and helper CD4 T cells specific for donor anfigens. Typically, this help occurs in germinal centers within secondary lymphoid organs and is dependent on CD40/CD154 cosfimulatory pathway. However, the T cell repertoire of many humans contains alloreacfive memory T cells that are resistant to immunosuppression or cosfimulatory blockade. Our preliminary data show that donor-reactive memory CD4 T cells induce higher titers of alloAb compared to naive CD4 T cells even in the absence of conventional germinal center formafion and CD40/CD154 interacfion. However, the mechanisms underiying the observed high alloAb titers as well as anatomical sites and molecular requirements of help by memory CD4 T cells are sfill unknown and need to be tested. The goal of this study is to identify functional phenotype of memory CD4 T cells providing help for alloreacfive B cells and to investigate the characteristic features and requirements for this help. We have developed a mouse model of kidney transplantation to study donor-specific alloAb responses induced by memory CD4 T cells. We hypothesize that compared to naive cells, memory CD4 T cells inifiate enhanced development of GCs and greater proliferation of B cells, promote production of alloAb with higher affinifies for donor antigens and induce enhanced development of long-lived Ab secrefing plasma cells and memory B cells. We further propose that while follicular helper memory T cells are superior in inducing alloAb responses compared to other lineages, help by memory CD4 T cells can occur outside of typical germinal centers and can bypass the requirement for CD40/CD154 interacfion via alternative molecular pathways such as TLR and BAFF/APRIL signaling. We will test this hypothesis in three Specific Aims: Aim 1. To investigate the mechanisms of superior alloantibody production induced by donor-specific memory CD4 T cells in response to renal allografts. Aim 2. To identify functional phenotype of memory CD4 T cells capable of providing help for alloantibody production after renal allograft placement. Aim 3. To determine the location and molecular requirements of help provided by memory CD4 T cells for alloantibody production.

Public health relevance
Antibody-mediated injury to transplanted organ is a significant problem in modern clinical transplantation. In conjunction with two other projects in the program, this work will provide valuable insights into the mechanisms of acute humoral rejection of renal allogtrafts. The generated information may be used to identify recipients with high risk of de novo alloAb production and to design future therapies aimed at preventing alloAb production in T cell sensitized transplant patients.